Core B: University of Kentucky Alzheimer's Disease Core Center

Project Summary/Abstract: Clinical Core
The Clinical Core of the UK-ADRC maintains a well-characterized, community-based cohort focused on
normal aging and early transitional disease states and follows individuals longitudinally until brain autopsy.
We maintain a mandatory autopsy requirement for all subjects (with the exception of our Minority Gateway
Clinic, where autopsy is promoted but not required), allowing major contributions in the area of clinical-
pathological correlative studies, and definition of early preclinical and pre-dementia disease states. These
efforts have been a driving force in our recognition of the heterogeneity of community-acquired dementia,
including major contributions to the field in regard to LATE, PART, VCID, and the role these pathologic
states play in conjunction with traditional AD, LBD, and FTLD disease states. A major focus of our work has
also been on defining early clinical transitions involving the interplay of these disease states that has driven
the widespread exploration of late-life multi-etiology dementia syndromes. To further such advances, the
UK-ADRC Clinical Core emphasizes deep clinical, biomarker, genetic, and post-mortem phenotyping of a
diverse cohort of elderly subjects at high risk for multi-etiology dementia. Major initiatives in the area of AD
mimics and transitions from normal to late-life multi-etiology dementia are well-poised to continue to move the
field forward in the areas of both diagnosis and translational interventional discoveries. We have introduced
exciting new initiatives in our expansion of antemortem biomarker research allowing an even deeper clinical
phenotyping of our participants as we work towards translational discoveries for multi-etiology dementia. The
UK-ADRC will continue to constantly evolve in dynamic ways through our proposed specific aims.
Aim 1: Maintain & longitudinally characterize a central longitudinal cohort enrolling cognitively normal subjects
to facilitate our understanding of preclinical disease and early cognitive transitions to multi-etiology MCI &
dementia.
Aim 2: Maintain and expand our successful Minority Gateway Clinics to maintain and grow our (significantly)
above-parity for population minority engagement.
Aim 3: Further develop and maintain an infrastructure to support translational therapeutic development through
all clinical trial phases in support of NIH, ADCS, ACTC initiatives, industry-sponsored drug trials, and
investigator-initiated projects.
Aim 4: Foster education and support of research participants and families to ensure that our efforts are
clinically meaningful, both in novel prevention studies as well as treatment in established disease
Overall, the Clinical Core will continue to provide an infrastructure and environment that will continue to
contribute to our success in advancing multidisciplinary, innovative AD research supporting our center theme
of Transitions from Normal to Late-Life Multi-Etiology Dementia.

Public health relevance
Per RFA-AG-21-019: Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.